Spreading Depolarization and Progression of Developmental Epileptic Encephalopathy

PROJECT SUMMARY
Spreading depolarization (SD) is a wave of massive, near-complete cellular depolarization that slowly
propagates across brain tissue. Recent decades of clinical studies have convincingly demonstrated that this
prolonged depolarization wave occurs under certain conditions in the human brain and can contribute to
deleterious acute and chronic neurological deficits. SD is distantly related to seizures, and their co-occurrence
has been observed in numerous clinical and experimental settings. However, the majority of the findings are
based on experimentally evoked SD, often in anesthetized animals. It remains an open question whether SD
spontaneously emerges and contributes to neurological comorbidities in epilepsy patients.
In order to address the neurological significance of spontaneous SD, we recently developed a chronic DC-band
EEG recording and demonstrated that SD events indeed occur spontaneously in awake genetic and acquired
epilepsy mouse models, each exhibiting distinct generation patterns and interactions with seizures unique to the
respective models. With advanced multimodal electrophysiological and state-of-the-art behavioral analysis tools,
we are now investigating both the neurological consequences and underlying regulatory mechanisms of these
pathophysiological depolarizations in hyperexcitable neuronal circuitries.
This project will investigate the contributions of SD to epilepsy comorbidities and disease progression in Dravet
syndrome, a major example of developmental epileptic encephalopathy (DEE), using a well-established Scn1a
deficient mouse model (Scn1a+/R1407X). Leveraging our expertise in acute and chronic electrophysiological
monitoring in awake juvenile mice, we will thoroughly characterize the pathological significance of SD events in
the developing juvenile Scn1a+/R1407X mice, in which the risk of premature mortality is high, neurobehavioral
abnormalities begin to emerge, and spontaneous cortical and subcortical SD are present.
Specifically, we will investigate 1) the correlation between SD and cardiorespiratory instability (AIM1), 2) acute
and chronic neurobehavioral deficits associated with SD (AIM2), and 3) the contribution of hippocampal SD
during early-life hyperthermic seizure to subsequent circuit dysfunctions (AIM3). These studies will investigate
the understudied SD pathology in the well-established DS mouse model.
These studies will examine the pathological significance of understudied SD phenomenon in the one of the one
of the most studied mouse model of DEEs. The experimental methods established in this study will be directly
applied to other epilepsy mouse models in our laboratory, further elucidating the general and disease-specific
role of SD. The results obtained in this study may also provide insights into other SD-related pathologies such
as stroke, traumatic brain injury, and migraine with aura.

Public health relevance
Project Narrative This project will investigate the role of a brain phenomenon called spreading depolarization (SD) in the genetic epilepsy mouse model of Dravet syndrome. We will investigate how SD affects their physiology and behavior, and identify how such a massive depolarization is regulated.